Structural basis for human astrovirus entry

PROJECT SUMMARY
Human astroviruses (HAstV) are a leading cause of viral diarrhea in children. Currently, no vaccines or antiviral
therapies exist for HAstV infections. Our goal is to identify essential functional sites on the HAstV surface that
can be exploited for the development of preventative and therapeutic strategies against HAstV. The HAstV virion
is a small, icosahedral virus composed of an RNA genome surrounded by capsid protein. HAstV enters cells
through clathrin-mediated endocytosis. The human neonatal Fc receptor (FcRn) was recently identified as a
functional receptor for HAstV entry into human cells, and dipeptidyl-peptidase IV (DPP4) was identified as a
cofactor for HAstV entry. However, the molecular basis for HAstV interaction with these receptors is unknown,
and the mechanism by which these receptors promote virus entry is unknown. Our central hypothesis is that the
HAstV capsid spike domain engages FcRn in the endosome to promote virus genome release. Using innovative
structural, biophysical, and virological approaches, we will pursue two specific aims to (1) define the atomic
interactions, affinity, and specificity of the HAstV capsid for FcRn, and (2) define the roles of FcRn and DPP4 for
HAstV attachment, internalization, capsid structural changes, and genome release. Results obtained by this work
will elucidate mechanisms of HAstV entry and provide a foundation for the design of vaccines and therapeutics
to prevent and treat HAstV infections.

Public health relevance
PROJECT NARRATIVE Human astroviruses are a leading cause of viral diarrhea in young children, hospitalized patients, and the elderly. This proposal seeks to understand at the atomic level how human astrovirus engages human receptors and promotes virus genome release. These findings will be important for understanding key vulnerabilities on the virus surface and developing a vaccine and treatments for astrovirus diarrhea.